Methods in Nephrologic Research

Project Summary
This is an application for renewal of a longstanding program to provide intensive post-doctoral training in
modern methods of nephrologic research. Continued funding of six stipends per year is requested for this joint
training program that provides support for clinically trained, research-track nephrology fellows in both our adult
and pediatric nephrology programs. Although the highest priority of this program is to train physician-scientists,
there is also a strong commitment to the training of basic scientist trainees with the Ph.D. degree for careers in
kidney research.
Each year up to 3 new trainees are recruited into the program after completing residency training in
internal medicine or pediatrics. Only fellows with a strong commitment to multi-year research training are
recruited into the program. Additional basic science trainees may also be recruited into the program when
appropriate. Training is provided in both laboratory-based and patient-oriented research. The training faculty is
drawn from multiple clinical and basic science departments (Internal Medicine, Pediatrics, Biomedical
Engineering, Cellular and Molecular Physiology, Cell Biology, Epidemiology and Public Health, Genetics,
Immunobiology, Pathology, Pharmacology) and spans diverse biomedical disciplines relevant to kidney
disease research: electrolyte physiology and pathophysiology, cell biology and experimental pathology,
biostatistics, genetics and developmental biology, immunology and transplantation, vascular biology, tissue
engineering, and clinical epidemiology.
Although the core of research training is provided through work on a selected research topic under the
supervision of an individual preceptor, training is enhanced by a mentoring committee made up of the primary
mentor, a secondary mentor and one of the program directors, as well as a broad array of teaching
conferences, seminars and courses. Indeed, many of our trainees enroll in graduate degree programs
specifically designed for training clinician investigators, including the Investigative Medicine Ph.D. program and
the Program in Chronic Disease Epidemiology that leads to a Master of Science in Epidemiology and Public
Health.
Over the past 40 years this program has trained many leaders in academic nephrology, and the recent
track record continues to be outstanding. The majority of trainees who completed training during the past 15
years currently hold either full-time academic positions or research-related positions in industry, and many
have successfully competed for career development faculty grants from the NIH or American Heart Association
(e.g. K08, K23, Fellow-to-Faculty Transition Award) or have already obtained NIH R01 grants. The program
continues to have a strong commitment to achieving ethnic diversity, and has successfully recruited and
trained many underrepresented minority candidates over the past 15 year period.

Public health relevance
Project Narrative Kidney diseases have an enormous impact on the health of Americans and on our nation's health care costs. The goal of the proposed program is to train physician-scientists and basic scientists for academic and research careers dedicated to understanding the mechanisms that cause kidney diseases and to developing new strategies for the prevention and treatment of kidney diseases.